Understanding the effects of the Oncology Care Model on cancer care for dual eligible patients

PROJECT SUMMARY/ABSTRACT
Candidate: Lindsey Herrel, MD, MS is a urologic oncologist and junior health services
researcher focused on improving cancer care for vulnerable populations through health policy
reform. Dr. Herrel's long-term career goal is to become an independent surgeon-scientist
evaluating healthcare policies that impact vulnerable populations with cancer, with the ability to
translate research findings through healthcare policy reform.
Research Context: Nearly 900,000 Medicare beneficiaries are diagnosed with cancer annually,
with costs exceeding $34 billion. The Oncology Care Model, which is the first alternative
payment model in cancer, incentivizes physicians to provide higher quality care at a lower cost.
For dual eligible beneficiaries who qualify for Medicare due to elderly status and Medicaid due
to low income, programs such as OCM that reward improvements in quality and reductions
spending through care coordination, may offer a unique opportunity to improve cancer care for
these vulnerable populations. However, this program may also lead to adverse selection and
limited access if financial incentives are not properly aligned.
Specific Aims: 1) To better understand practice level variation in OCM participation for dual
eligible beneficiaries. 2) To examine the effect of OCM participation on quality of cancer care
and spending for duals. 3) To evaluate the impact of alternative payment strategies on cancer
care for dual eligible beneficiaries.
Research Plan: Dr. Herrel will use Medicare claims and methodology consistent with current
policy to characterize practices participating in OCM, in particular where duals are receiving
cancer care. She will then use advanced econometric methods to evaluate the effect of the
OCM policy on improving quality and reducing spending for duals. Finally, she will determine if
current financial incentives are properly aligned with caring for duals and will assess if alternate
payment strategies may provide greater motivation to care for duals.
Career Development Plan: In parallel with this research plan and under the guidance of well-
established mentors, Dr. Herrel will develop expertise in: 1) health equity for vulnerable
populations and dual eligible beneficiaries; 2) legislative and regulatory aspects of health policy;
3) advanced econometric analyses for policy evaluation and simulation.

Public health relevance
PROJECT NARRATIVE The Oncology Care Model is the first alternative payment model in cancer care and is designed to improve quality of cancer care and reduce overall spending. Dual eligible beneficiaries, with their complex medical and social care needs, may significantly benefit from the increased care coordination and resources offered through this policy, or may have limited access to care if financial incentives are improperly aligned. The overarching goal of this proposal is to harness advanced quantitative methods for health policy evaluation to understand the impact of the Oncology Care Model on cancer care for dual eligible beneficiaries.